Characterizing the Renal Immune Microenvironment in Antibody-Mediated Rejection to Predict Treatment Response using Imaging Mass Cytometry

PROJECT SUMMARY
The immune response of solid organ transplant rejection is a complex process that can lead to the loss of the
transplanted organ. Transplant rejection is broadly characterized as antibody-mediated rejection (ABMR) and T
cell-mediated rejection (TCMR) with evidence showing that ABMR confers a higher risk for graft loss. A significant
number of renal biopsies exhibit a mixed TCMR/ABMR phenotype, suggesting there is more disease overlap
than previously known. Unfortunately, irreversible graft damage often predates the diagnosis of ABMR, and
treatment options are costly with debatable efficacy, underscoring the need for improved earlier diagnostics and
prognostics. Evidence supports that local renal immune microenvironment dysregulation may play a significant
role in renal rejection pathobiology. This proposal aims to address the limitations of current histopathological
assessments in predicting post-transplant outcomes by providing a granular atlas of the immune cell interactions
and spatial distributions in the renal microenvironment. The central hypothesis of this proposal posits that higher
abundance, interactions, and activity of cytotoxic immune cell subsets correlate with more severe ABMR disease
and worse treatment responses. To test this hypothesis, we will utilize advanced imaging mass cytometry to
comprehensively profile the immune cells and their functional states within kidney tissues. Experiments proposed
in Aim 1 will establish an immune atlas that differentiates between ABMR and TCMR by examining immune cell
phenotypes, functions, and spatial patterns in renal biopsies. Aim 2 will integrate this immune data with clinical
variables to develop predictive models for treatment response, using a novel machine learning algorithm
specifically designed for high-dimensional data analysis. This work will be completed at Stanford University
School of Medicine in Dr. Brice Gaudilliere’s laboratory (primary sponsor) with guidance from Dr. Minnie Sarwal
(co-sponsor, UCSF). The proposed rigorous training plan harnesses cutting-edge high-dimensional single-cell
spatial immune profiling with sparse machine learning methods. The training, approach, and results generated
will offer a unique framework for future research on cytotoxic mechanisms of renal transplant rejection, aiding
my career development and enabling me to develop the expertise in transplant immunology and computational
biology necessary for becoming an independent academic translational physician-scientist. Importantly, these
findings will enhance our understanding of the immune dynamics in kidney transplantation and pave the way for
innovative diagnostic tools and therapeutic interventions, ultimately improving patient outcomes and graft
survival rates. This research holds significant promise for advancing personalized medicine in the field of organ
transplantation.

Public health relevance
PROJECT NARRATIVE Kidney transplant rejection involves complex local immune mechanisms that can ultimately result in the loss of the transplanted organ, affecting up to 30% of transplanted kidneys in the US. This proposal aims to profile the renal immune landscape in biopsy samples from both stable grafts and those showing signs of rejection with the goal to identify the specific immune responses that contribute to antibody-mediated rejection (ABMR) and develop predictive tools for treatment response. This crucial information could lead to targets for new diagnostics and therapeutics, ultimately improving patient outcomes and reducing the burden of graft loss on the healthcare system.